JAX Diversity Action Plan (DAP) Post-Baccalaureate Program in Genomics (gDAP)

PROJECT SUMMARY/ABSTRACT
The goal of The Jackson Laboratory (JAX) Diversity Action Plan (DAP) post-baccalaureate program in genomics
is to provide a transformative, mentored research experience for individuals from underrepresented groups with
an emphasis on trainees whose goals are to pursue advanced degrees and careers in genome-related fields.
Low participation in STEM (Science, Technology, Engineering, and Mathematics) by individuals from
underrepresented groups is a recognized problem nationally (National Academies Press, 2011). Lack of
exposure to scientific research resources and mentors, economic factors, and cultural biases are barriers that
limit access to quality science education and, in turn, hinder the expansion of our nation's research capacity by
limiting contributions from a deep pool of intellectual talent.
The program will benefit from JAX's nine decades of success in training scientists at all career stages, including
those from underrepresented groups, by its world-leading mouse genetic, genomic, and computational
resources, and by its well-funded and productive faculty. The program will build upon programmatic infrastructure
for career development and a community of post-bacc peers from an existing post-bacc program at JAX. The
genomics DAP will be distinct from the existing post-bacc program as the focus for the proposed program will
be specifically on career development for basic research in the areas of genomics, genome technology, and data
science.
The program will host up to six post-baccalaureate fellows in a year with individuals distributed across the Bar
Harbor, Maine and Farmington, Connecticut JAX campuses. The three primary aims for the program will be (1)
Provide two-year mentored post-baccalaureate research experiences in genomics, genome technologies, and
data science for individuals from underrepresented minority groups; (2) Implement a curriculum that provides
knowledge, skills, and training complementary to the mentored laboratory research experience and, (3)
Incorporate formal and informal evaluation methods to strengthen the training program. Oversight for the
program will be provided by two PIs, one from each campus, and by Program Staff from the JAX Genomic
Education team. An Advisory Council comprised of internal and external individuals will evaluate the program's
effectiveness and provide guidance on sustaining a research workplace that is inclusive and equitable.
The alumni from the post-bacc program will contribute to building a research workforce that is representative of
our nation's population. They will bring unique perspectives and individual enterprise to setting and advancing a
research agenda in genomics and data science that benefits all people.

Public health relevance
RELEVANCE TO PUBLIC HEALTH A diverse workforce in the biomedical sciences is key to fostering scientific innovation and to addressing health disparities in underserved populations in the United States. The post-baccalaureate training program at The Jackson Laboratory offers individuals who identify with groups currently underrepresented in biomedical research exceptional career development opportunities through the conduct of research under the mentorship of investigators who are leaders in genomics, genomic technologies, and data science. Alumni of this immersive research experience will have the foundational knowledge as well as the technical, research, communication, and professional skills needed for successful and productive careers in biomedical research.